Planning Grant: Developing the Research Capacity to Investigate the Practice of Geophagy Among Pregnant Mothers and Impacts on Children's Neurodevelopment

Abstract: Pica is the craving for and deliberate consumption of nonfood items. Geophagy is the ingestion of earth, one of the most common forms of pica. Geophagy is more prevalent among pregnant mothers in sub- Saharan Africa, with reported rates ranging up to 87%. Pica, including the practice of geophagy, has also been documented in the USA; however, the rate of geophagy is lower compared to sub-Saharan Africa. Maternal ingestion of soil/clay potentially exposes the developing fetus to dangerous levels of heavy metals, including lead, arsenic, and manganese, which are known to adversely impact children’s neurodevelopment. Moreover, maternal ingestion of soil/clay may diminish the capacity of the gut microbiota to perform critical functions, which (directly or indirectly) impact fetal brain development. This planning grant will strengthen the collaboration between Oregon State University and two institutions in Ndola, Zambia, including the Tropical Diseases Research Centre (TDRC) and Copperbelt University, School of Medicine (CBU-SOM).
Aim 1. To the best of our knowledge, the expertise to assess children’s neurodevelopment is lacking in Ndola, Zambia. Researchers at the TDRC and CBU-SOM will be trained to assess children’s neurodevelopment using the Bayley Scales of Infant Development, 4th Edition (BSID-4).
Aim 2. Among 200 HIV-negative mothers/offspring enrolled at parturition, we will assess the practice of geophagy, maternal exposure to heavy metals, and impacts of maternal geophagy on children’s neurodevelopment at 12-months of age using BSID-4.
Aim 3. Among enrolled mothers, we will determine whether the community structure of the gut microbiota differs between geophageous and non-geophageous mothers using 16S rRNA gene profiling.
Aim 4. Working with an Advisory Board comprised of Zambian public health practitioners, we will investigate sustainable alternatives to the practice of geophagy. Potential interventions will be tested in a larger cohort of pregnant mothers in the full study. This study will increase the capacity of both institutions in Ndola, Zambia, to conduct environmental health research and assess children’s neurodevelopment. The long-term goal of this study is to reduce the practice of geophagy among pregnant mothers, by conducting evidence-based research to inform public health officials concerning the risks of geophagy. Because mothers pass down this practice to their children, reducing maternal ingestion of soil/clay will also likely reduce this practice among their children. The results from this study are applicable to the USA population, where geophagy has also been documented

Public health relevance
Narrative The long-term goal of this study is to implement alternatives to the practice of geophagy among pregnant mothers. Study findings will help improve maternal nutrition during pregnancy, which will improve children’s health and neurodevelopment. The results from this study are applicable to the USA population, where geophagy has also been documented among mothers.